Investigating the Mechanisms and Impact of Amyloid-Beta Mediated Disruption of Synaptic Nanoachitecture

Project Summary
The nanoscale organization of key synaptic proteins is now considered an important contributor to synaptic
activity and plasticity. However, there is a lack of research on how such delicate nano-organization might be
involved in brain diseases, which often directly impact synaptic function. Alzheimer’s Disease (AD) is associated
with brain accumulation of the Amyloid-Beta (Aß) peptide. Furthermore, oligomeric assemblies of the 42 amino
acid variant, Aß42, which directly target synapses, have been found especially pernicious toward synaptic
function. In preliminary research, I have observed through multiple replicates that a brief, 15-minute application
of 500 nM Aß is sufficient to disrupt existing synaptic nanostructure. This manifests as the addition of nanoscale
objects of the PSD95 scaffolding protein, and of GluA1 subunit-containing AMPA-type glutamate receptors, a
phenomenon we have titled, “fragmentation”. As this observation occurs along the same timescale as Aß-
mediated NMDA-type glutamate receptor dysfunction and deficits to LTP (Long-Term Potentiation), I hypothesize
that Aß-mediated fragmentation of synaptic nanostructure ultimately leads to deficits in synapse function and
plasticity. In this proposal, I aim to thoroughly characterize both the kinetics, and dose-response of Aß-mediated
fragmentation, as well as to what extent this fragmentation occurs (i.e., does fragmentation include select
synaptic proteins, or completely restructure synaptic nanoarchitecture). I also plan to assess what signaling
mechanisms underlie Aß-mediated fragmentation and whether these are similar, or distinct from already
established mechanisms causing Aß-mediated synaptic dysfunction. Lastly, my preliminary data show that I can
prevent the fragmentation of AMPAR nanostructure at the synapse by crosslinking receptors with a GluA1
antibody prior to Aß exposure. Using this method, as well as others our lab has developed, I will then test whether
Aß-mediated synaptic nanostructure fragmentation is responsible for LTP deficits and synapse loss.
Importantly, this fellowship proposal provides the opportunity for my extensive training in multiple experimental
techniques including: super-resolution microscopy (multicolor and live-cell STED imaging, including preparation
of STED-dye conjugated primary antibodies), writing computer based imaging-analyses, receptor signaling
pharmacology, molecular cloning (CRISPR-based knockout / knockin strategies, optogenetic / chemogenetic
construct design), electrophysiology and Ca2+ imaging, and 2-photon glutamate uncaging.

Public health relevance
Project Narrative Alzheimer’s Disease (AD) is a significant global health crisis, affecting approximately 55 million people worldwide, and around 6.7 million individuals in the United States alone. This disease causes dementia, memory loss and cognitive decline, and entails the disruption of the communication between brain cells, neurons, at small structures called synapses, by Amyloid-Beta, one of several proteins of interest frequently researched in context of AD. This research aims to uncover how a recently described phenomenon, whereby the nano-scale organization of specific synaptic proteins is disrupted by Amyloid-Beta, might underlie previously researched disruptions to synaptic activity, and the loss of synapses.